RFA-DP-21-001 Georgia Pregnancy Risk Assessment Monitoring System (PRAMS) Project

Project Summary
The Georgia Pregnancy Risk Assessment Monitoring System (PRAMS) Project is a statewide,
ongoing population‐based survey that collects information on women with a recent live birth in
Georgia. Georgia PRAMS initiated sampling with January 1993 births. PRAMS survey data
complements Vital Records data by collecting information about mothers’ attitudes, behaviors,
and experiences before, during, and shortly after pregnancy. Survey topics include
preconception health, pregnancy intention, prenatal care, health insurance, oral health during
pregnancy, substance use, breastfeeding, safe sleep behaviors and environment, intimate
partner violence, maternal stressors, contraception use and methods, and supplemental topics
as emergent public health issues arise (ex: Zika Virus, Coronavirus Disease 2019), among
others. Each month, a stratified random sample of approximately 110 women is drawn from
birth certificate records accessed through the State Office of Vital Records. The current
stratification variable is preterm birth (gestational age greater than 20 and less than 37 weeks
versus all other births). The stratification scheme can vary by year and is used to ensure
adequate representation of key subgroups in the sample. Sampled PRAMS participants are
surveyed two to six months after delivery of their infant first by mail and then by phone if a mail
survey response is not received. Each mother’s survey is linked to her infant’s birth certificate.
The goal of the Georgia PRAMS Project is to provide population-based data on maternal
experiences and behaviors before, during, and after pregnancy and during early infancy which
can be used to reduce the risk of adverse birth outcomes and improve the health of mothers
and infants in Georgia. Georgia PRAMS is the only data source for many key indicators of
maternal and child health in the state, providing essential data to identify disparities, select
maternal and child health priorities, inform and evaluate programs, and inform policy changes to
improve the health of all mothers and infants in Georgia.

Public health relevance
Project Narrative The Georgia Pregnancy Risk Assessment Monitoring System (PRAMS) Project will continue to collect population-based data on women’s attitudes, experiences, and behaviors before, during, and shortly after delivering a live birth in Georgia. Mothers will be contacted by mail, phone and web (when it becomes available). The information gained from this surveillance system will be used to identify risk factors and disparities in adverse birth outcomes, determine maternal and child health priorities, develop and evaluate programmatic interventions, and inform policies that will improve the health of mothers and infants in Georgia.